2022 Hybrid Annual Educational Conference (AEC) & Exhibition

Project Summary/Abstract
The National Environmental Health Association (NEHA), a 501(c)3 nonprofit organization, is
pleased to submit an application for funding assistance under the U.S. Food and Drug
Administration (FDA) Support for Conferences and Scientific Meetings (R13 Clinical Trial Not
Allowed), FOA Number: PAR-19-306.
Despite the overwhelming challenges brought on by the COVID-19 pandemic, environmental
health (EH) professionals continue to seek critical continuing education and training resources.
With the large variance of travel restrictions in place around the country and globe—coupled
with the demand for in-person opportunities to connect, engage, and expand networks—NEHA
has transitioned the 2022 Annual Educational Conference (AEC) & Exhibition to a hybrid
conference on June 28–July 1 in Spokane, Washington and virtually.
The AEC is designed to train, educate, and advance EH professionals, as well as bring people
together both in-person and virtually to build a network of EH colleagues, exchange information,
and discover new and practical solutions to food safety and other EH issues. The AEC brings
together over 1,000 state, local, tribal, territorial, and federal EH and public health professionals
from health and environmental protection agencies as well as the private sector, academia,
uniformed services, and international jurisdictions. The AEC provides a means to translate field-
based research into action on food safety and other EH topics and address environmental
exposures and health risks. The theme for the NEHA 2022 AEC is “Safeguarding a Road Less
Traveled.” EH professionals have been on the frontline of an unprecedented pandemic. COVID-
19 brought with it changes to roles and increased responsibilities. The 2022 AEC will bring
together EH professionals to share experiences, research, expertise, and best practices as we
work together in safeguarding a new post-pandemic world.
The vision of FDA’s Office of Regulatory Affairs that “all food is safe…and the public health is
advanced and protected,” as well as its mission to protect consumers and enhance public health
by maximizing compliance and minimizing risk aligns with NEHA’s mission to “build, sustain, and
empower an effective environmental health workforce.” Both missions are embodied in the AEC.
NEHA requests funding assistance to develop, administer, and conduct the 2022 AEC. NEHA
anticipates an estimated cost of $750,000 for the 2022 Hybrid AEC and is requesting assistance
in the amount of $50,000. NEHA requests funding to assist with virtual platform and audio/visual
costs necessary to provide high quality education to meet the needs of EH professionals.

Public health relevance
Project Narrative Due to the COVID-19 pandemic, social distancing, shelter-in-place orders, and the cancelation of local conferences, meetings, and events over the last 2 years, environmental health (EH) professionals are in need of in-person educational opportunities to connect and engage with peers to build capacity for their organizations and the communities they serve. The National Environmental Health Association (NEHA) 2022 Annual Educational Conference (AEC) & Exhibition will build upon the 2021 AEC Virtual Series theme, “Together a Safer and Healthier Tomorrow,” as EH professionals work together in 2022 in “Safeguarding a Road Less Traveled.” Attendees will have the opportunity to share experiences, research, expertise, and best practices as we work together in safeguarding a new post-pandemic world for the communities we serve.